RFA-IP-22-001 - Burden and sequelae of influenza, SARS-CoV-2 and other respiratory viruses associated Severe Acute Respiratory Infections among Indian adult population aged 18-60yrs

Project Summary
As a logical extension of the work done by the team at the All India Institute of Medical
Science, New Delhi, this work will expand to include more geographically diverse sites
and address adults who have not been adequately studied but who due to their
productivity can dis-appropriately contribute to the overall economic burden. The
proposal intends to execute a series of inter-related activities to support evidence-based
policy development to address Influenza and SARSCo-V2 infection in working adult
population of India. The specific objectives are to estimate the incidence and treatment
cost of Influenza and SARS-CoV-2 associated Severe Acute Respiratory Infections (SARI)
among adults aged 18-60 years and characterize the detected viruses; to estimate the
incidence of short and long-term sequelae of Influenza and SARS-CoV-2 associated SARI
and risk of re-infection; to assess vaccine hesitancy and uptake among health care workers
and estimate the effectiveness of influenza and COVID-19 vaccines against serious illness
and finally, conduct capacity building initiatives for health professionals and advocate for
public health approach for prevention and control of influenza and COVID-19 disease in
India among key stakeholders.
This will be done by setting up Indian National SARI Platform for Influenza and other
Respiratory Pathogens (INSPIRES) a multi-centric network of public tertiary hospitals
with three components – hospital-based SARI Registry with a cohort of Influenza or
COVID-19 patients with a linked community site and a cohort of healthcare workers. The
platform will consist of geographically spread 10-12 medical colleges which routinely
admit and manage SARI cases. The patients with severe acute respiratory infection
(SARI) admitted and testing positive for identified pathogens i.e., influenza and SARS
CoV-2. The community-based SARI surveillance to be conducted in the catchment area
of the hospitals will estimate SARI incidence rates. Combining the two will provide agent-
specific SARI rates for each participating site. A cohort of influenza and SARS CoV-2
positive patients identified above will be followed for two years after enrolment to look at
pulmonary, cardiac, cognition, functional status and quality of life parameters. A cohort
of health care workers in the study hospitals will be followed up for the duration of the
study. After a baseline assessment of their vaccine uptake and hesitancy, they will be
sensitized to the need for vaccination and offered free vaccines (both influenza and
COVID-19) as per the hospital policy. All participants will be followed up for a period of
two years for development of symptomatic Influenza or SARS CoV2 infection. A
Respiratory viruses Resource Centre will be set up at AIIMS New Delhi to prepae training
and advocacy materials for liaising with a diverse set of stakeholders ranging from general
population, healthcare professionals to policy makers.

Public health relevance
Project Narrative This study will generate information on health system and economic impact of Influenza and SARSCoV-2 related severe acute respiratory infections among adults in India. Such information from Low-middle income countries is sparse. In addition, this will strengthen capacity among the participating institutions to conduct disease registries and cohort to assess long-term sequelae of such infections. The evidence so generated will be disseminated to provincial and national government through a well thought out advocacy strategy leading to mitigation of the impact of these two infections in the community.